Pathophysiology of Tubular Aggregate Myopathy

Tubular aggregate myopathy (TAM) is an inherited muscle disease associated with progressive weakness,
cramps, myalgia, and exercise intolerance that primarily affects proximal muscles of the lower limbs. The
extensive presence of tubular aggregates (TAs), arrays of ordered and densely packed sarcoplasmic reticulum
(SR) tubes, in muscle biopsies from TAM patients represents a key histopathological hallmark of this disease.
Recent studies have linked TAM to gain-of-function mutations in the Stim1, Orai1, and Casq1 genes. The
proteins encoded by these genes coordinate store operated Ca2+ entry (SOCE), a mechanism that enables
muscle to replenish SR Ca2+ stores needed to maintain force production. TAM mutations in Stim1, Orai1 and
Casq1 are thought to promote constitutively active Ca2+ entry that serves as an upstream driver for an age-
dependent myopathy with TAs. However, the precise downstream cellular and molecular mechanisms involved
remain to be elucidated. To date, there is no cure or effective treatment for patients suffering from TAM.
To identify downstream pathogenic mechanisms, as well as test and validate effective therapeutic
interventions, we generated knock-in mice with a G100S TAM mutation in Orai1 (Orai1G100S/+) and a separate
line of mice with a D44N TAM mutation in Casq1 (Casq1D44N/+). Consistent with that observed in TAM patients,
Orai1G100S/+ mice exhibit a myopathy characterized by weakness, exercise intolerance, elevated creatine
kinase levels and TAs, while Casq1D44N/+ mice exhibit a milder, later onset phenotype with an age-dependent
increase in TAs. We also found that TAs are reduced and force production increased after housing Orai1G100S/+
mice for 6 months in cages with voluntary running wheels. We will use these TAM mouse models to investigate
mechanisms of disease pathogenesis, muscle adaptations, and test novel therapeutic interventions.
The Overall Hypothesis of this proposal is that gain-of-function TAM mutations in Orai1 and Casq1 result in
uncontrolled, constitutive Ca2+ entry during early muscle development that drives a transcriptional program that
initially reduces aberrant Orai1 function, but ultimately, leads to a myopathy characterized by TAs. We further
hypothesize that the myopathy and TAs in Orai1G100S/+ mice can be mitigated by early and late intervention with
exercise mimetic therapy. Aim 1 will characterize age- and sex-dependent changes in SOCE function, muscle
phenotype, TAs, muscle proteome and mitochondrial function in Orai1G100S/+ mice. Aim 2 will characterize age-
and sex-dependent changes in SOCE function, muscle phenotype, TAs, muscle proteome, and mitochondrial
function in Casq1D44N/+ mice. Aim 3 will assess the therapeutic potential of early and late intervention with an
exercise mimetic (150-500 mg/kg/day AICAR using osmotic minipumps) in preventing and reversing,
respectively, the myopathy observed in Orai1G100S/+ mice. Overall, the results will provide important new insights
into the pathogenesis of TAM and assess the therapeutic potential of exercise mimetic therapy in mitigating
TAM disease progression.

Public health relevance
Tubular aggregate myopathy (TAM) is an inherited muscle disease characterized by weakness, cramps, myalgia, and exercise intolerance. There is currently no cure or effective treatment for this debilitating muscle disease. This project will use two newly generated mouse models of TAM to provide insight into the pathophysiological mechanisms responsible for muscle dysfunction in this disease and assess the therapeutic potential of exercise mimetic therapy in mitigating disease progression.